Use of Oscillometry for the Evaluation of Pulmonary Function Following Pediatric Acute Respiratory Failure.

PROJECT SUMMARY
Acute respiratory failure, typically resulting from conditions such as pneumonia, bronchiolitis, or asthma, is the
most common cause of critical illness among U.S. children. The prevalence of acute respiratory failure has
risen four-fold in the past two decades to nearly half of children admitted to an ICU. As pediatric ICU mortality
has fallen to <3% of all admissions, there is a growing population of children surviving acute respiratory failure.
Little is known, however, about the impact of acute lung injury on long-term pulmonary function in children.
Multiple small studies have found that 30-80% of children surviving severe hypoxemic respiratory failure have
abnormal lung function following hospital discharge when assessed with spirometry, the most common method
of pulmonary function testing. This led the 2023 Pediatric Acute Lung Injury Consensus Conference to
recommend pulmonary function testing for all children surviving pediatric acute respiratory distress syndrome
who are able to perform spirometry. To participate in spirometry, however, children must be at least 6 years of
age with the cognitive ability to perform a forced expiratory maneuver. An estimated 70% of children who
become critically ill with acute respiratory illnesses are younger than 6 years or have cognitive impairment, and
there are no established methods to feasibly assess pulmonary function in these populations. Oscillometry is a
passive breathing technique to assess lung function that requires no patient effort, and the introduction of
small, portable oscillometry devices has led to an increase in its use in recent years among children with
chronic lung diseases. It has not been tested among children with acute pulmonary processes, which have
different pathophysiologic mechanisms and anticipated trajectories than chronic lung diseases. The overall
objective of this proposal is to assess the ability of oscillometry to identify and characterize recovery of
pulmonary function among children surviving acute respiratory failure. We will conduct a longitudinal cohort
study of 150 children surviving acute respiratory failure in three quaternary care pediatric ICUs, using
oscillometry to measure pulmonary function at hospital discharge and 3 months post-discharge among two
cohorts of children who are and are not able to participate in spirometry. We aim to 1) compare change in
pulmonary function from discharge to 3 months measured by oscillometry stratified by age group, primary
pulmonary pathophysiologic process, and severity of lung disease; 2) assess the correlation between
oscillometry and spirometry at each timepoint and compare change from discharge to 3 months among
children performing both measures; and 3) evaluate associations between oscillometry and health-related
quality of life, activity participation, and respiratory symptoms, and the factors associated with recovery in each
domain. We will for the first time evaluate pulmonary function among children surviving acute respiratory failure
who are unable to cooperate with spirometry, allowing identification of a new set of patients who may benefit
from intervention previously excluded from screening for pulmonary dysfunction due to age or cognitive status.

Public health relevance
PROJECT NARRATIVE Given a high prevalence of ongoing pulmonary impairment among children surviving acute respiratory failure, international guidelines recommend that all children surviving pediatric acute respiratory distress syndrome undergo pulmonary function testing after hospital discharge. Children under 6 years of age and children with cognitive impairment are currently excluded from this screening, however, as spirometry is the only established method for pulmonary function testing following acute respiratory failure and it can only be performed in children able to perform forced exhalation. This proposal will evaluate the use of oscillometry, a non-volitional passive breathing technique, for assessment of pulmonary function among children surviving acute respiratory failure who are unable to complete spirometry to allow identification of pulmonary impairment that may be amenable to intervention among children of all ages and abilities.